Assessing food-specific tolerogenic CD4+ T cells in protection from food allergy

PROJECT SUMMARY/ABSTRACT
Food allergy is an increasingly common global medical issue with no cure and limited treatment options. Food
allergies are often lifelong and a leading cause of severe and/or fatal anaphylaxis, a rapid-onset systemic allergic
reaction. While type 2 immune responses and production of food-specific IgE and IgG antibodies are implicated in
food allergy, the immunologic mechanisms that regulate these processes are poorly understood. Human clinical
studies suggest that early oral exposure to food antigens decreases the risk of developing food allergy while
environmental exposures through non-oral routes, such as the skin or airways, increase the risk. Thus, route of
allergen exposure is considered a key factor determining clinical outcomes in food allergy. However, major
knowledge gaps remain as to whether and how oral consumption of foods provide systemic protection from
allergic sensitization and clinical manifestations of food allergy. Thus, the overall goal of this project is to better
understand the mechanisms by which oral exposure to food antigen protects from development of food allergy.
In a mouse model of food allergy, we have identified a critical role for T follicular helper (Tfh) cells in promoting
antigen-specific IgE production following intranasal (i.n.) or epicutaneous (e.c.) antigen exposure (considered
natural routes of sensitization in humans). Upon systemic challenge with antigen, sensitized mice showed clinical
symptoms of acute systemic anaphylaxis. Further, we found that oral consumption of antigen prior to i.n. or e.c.
exposure protected mice from developing food allergy. Interestingly, the protection was not associated with
expansion of conventional Foxp3-positive (Foxp3+) CD4+ T regulatory (Treg) cells but rather the emergence of
population(s) of CD4+ T cells expressing cytotoxic T-lymphocyte-associated protein 4 (CTLA-4) in draining lymph
nodes. Thus, the objective of this proposal is to leverage these models and address key questions regarding the
origins, phenotypes, and functions of these protective CTLA-4+ CD4+ T cells. Specifically, we hypothesize that
oral exposure to antigen induces tolerogenic non-canonical antigen-specific CD4+ T cells that prevent
systemic allergic sensitization to the same antigen and protect from development of IgE antibody and
anaphylaxis. Aim 1 will employ a mouse model of food allergy and oral tolerance to characterize antigen-specific
tolerogenic CD4+ T cells generated by oral exposure to food antigens through use of immunologic and genetic
tools. In Aim 2, we will investigate the physiologic functions of these T cells in preventing type 2 immune
responses and food allergy leveraging in vivo antibody blocking and adoptive transfer models. Overall, these
findings will identify mechanisms involved in food allergy development and prevention and facilitate more
effective and safer strategies to prevent and treat the disease in humans. Performance of these projects will help
to me to advance my experience and expertise with in vitro and in vivo immunological techniques and to learn
cutting-edge immunologic and genetic methods.

Public health relevance
PROJECT NARRATIVE Food allergies are adverse immune-mediated hypersensitivity responses to ingested food component(s) that are otherwise immunologically tolerated in healthy people. It is believed that oral route ingestion of antigen induces food-specific CD4+ T cells that protect against development of food allergy (i.e. oral tolerance). This proposal seeks to investigate how these food-specific CD4+ T cells provide systemic protection from allergic sensitization and clinical manifestations of food allergy.